Phase 2a/2b Study Emapalumab: A Window of Opportunity in Pediatric Aplastic Anemia

Abstract
Acquired aplastic anemia (AA) is a life-threatening disorder caused by an autoreactive T-cell mediated
destruction of hematopoietic stem cells resulting in the inability to produce adequate red blood cells, white blood
cells and platelets. Acquired AA is extremely rare, occurring in 2-6 patients per million. There are between 600-
900 new cases each year in the United States. While AA can occur at any age there is a bi-modal distribution
with peaks in late childhood/early adolescence and in older adults. Patients with AA are susceptible to potentially
fatal opportunistic infections, clonal hematopoiesis/leukemogenesis, and chronic transfusion burden.
The workup of a patient with suspected AA takes several weeks during which time the patient receives
only supportive care. Immune suppression therapy (IST) and bone marrow transplant (BMT) are the two
therapies available for patients once a diagnosis is definitive. For patients with an available matched related
donor (MRD), BMT is the standard of care (SOC). Patients lacking a MRD traditionally received IST although
many institutions are now prioritizing alternative donor transplant. IST has a 50% response rate over time with
the other half of patients requiring additional therapy. BMT has a higher disease-free survival rate but increased
potential toxicities including graft versus host disease, infertility and graft rejection. The decision of which therapy
to pursue is often the most anxiety-provoking time for families with children that have newly diagnosed AA.
This Phase 2a/2b Trial Emapalumab: A Window of Opportunity in Pediatric Aplastic Anemia leverages
data showing that the Interferon-gamma (IFNγ) pathway is associated with the pathogenesis of AA. Pediatric
patients with newly diagnosed AA will receive a prophase of an IFNγ neutralizing monoclonal antibody called
emapalumab. This prophase will not add time to curative therapy and will occur during the workup period
between presentation and start of definitive therapy. At the conclusion of the prophase, patients that have a
hematologic response will be consolidated with IST while those that do not will receive institutional SOC. In this
way we create an algorithm to try and identify patients that are most likely to have a favorable response to IST.
This data-driven identification of which patient should receive IST will help alleviate parental anxiety in making
these decisions without sufficient information.
Aim 2 of this project seeks to extend our previous findings that distinct patterns of pediatric clonal
hematopoiesis are associated with poor outcomes after IST. Conversely, lack of these markers aligned with
favorable IST responses. We will prospectively validate these findings and assess if these specific clonal
changes can be used as predictive biomarkers for response to IST. We will also examine if an early upfront
prophase with emapalumab can prevent and/or minimize emergence of clonal hematopoiesis by preserving
larger reservoirs of hematopoietic stem cells. By combining the data from these two aims, we hope to provide
an algorithm to identify pediatric patients with aplastic anemia that are most likely to be cured by IST.

Public health relevance
Project Narrative Pediatric acquired aplastic anemia is a life-threatening condition with frequently unknown origin caused by autoreactive T cell destruction of hematopoietic stem cells and inability to produce red blood cells, white blood cells and platelets. Treatment for aplastic anemia can be with immune suppression therapy or intensified with upfront bone marrow transplant. This proposal aims to provide algorithms to identify pediatric patients with newly diagnosed aplastic anemia that will respond favorably to IST, thereby improving cures while minimizing toxicity for this potentially fatal disease.